Implementation of electronic patient reported outcomes and impact on communication with patients

Project Abstract
This application is submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-23-041.
“Implementation of Electronic Patient Reported Outcomes and Impact on Communication with Patients”
leverages a unique opportunity (1) to evaluate sustainability of the use of an existing electronic symptom
management platform (eSym), and (2) to evaluate the impact of eSyM reporting on patient-clinician
communications. Since eSyM was recently developed and implemented at the Dartmouth Cancer Center
(DCC) for patients with gastrointestinal, thoracic, and gynecologic cancers, there is a critical need to rapidly
assess the sustainability of this digital platform beyond a six-site federally-funded type II hybrid effectiveness-
implementation cluster randomized trial (UM1 CA23080-01; NCT03850912), guided by RE-AIM and the
Dynamic Sustainability Framework. Further, we will also be able to assess tradeoffs between increasing
utilization of digital tools and potential for unintended consequences of a decrease in the quality of direct
patient-clinician communications as well as widening of the so-called digital divide in rural and aging
populations. Alternatively, collection of electronic patient reported outcomes as part of the eSyM platform may
enhance communication and patient-clinician partnerships in care delivery and coordination for patients with a
hematologic malignancy. This administrative supplement aligns with the NOSI by examining the effects of
digital tools on patient-clinician communications and supports the goals of DCC in addressing improved patient
outcomes through research in advancing patient-clinician communication, especially in underserved rural
populations.

Public health relevance
Project Narrative This proposal “Implementation of Electronic Patient Reported Outcomes and Impact on Communication with Patients” leverages a unique opportunity (1) to evaluate sustainability of the use of an existing electronic symptom management platform (eSym), and (2) to evaluate the impact of eSyM reporting on patient-clinician communications. There is a critical need to rapidly assess the sustainability of eSyM beyond a federally-funded type II hybrid effectiveness-implementation cluster randomized trial, which recently completed accrual across a six-site consortium. Further, we will also be able to assess tradeoffs between increasing utilization of digital tools and impact on direct patient-clinician communications as well as widening of the so-called digital divide in rural populations served by the Dartmouth Cancer Center.